The Integrative Genomics Viewer (IGV) for Cancer Research

Project Summary/Abstract
Driven by new and emerging technologies for data acquisition, integrative genomic studies are revolutionizing
the way we approach the study of cancer and charting the way to novel treatment regimens. They require the
high-throughput generation and analysis of multiple and often complex types of genomic data. To address this
challenge, and in active collaboration with end users, we developed, and released in 2008, a broadly applicable
Integrative Genomics Viewer (IGV). IGV is an interactive, high-performance, user-friendly tool launched millions
of times a year by investigators and clinicians worldwide. The goal of this project is to ensure that IGV continues
to track and respond to advances in genomics technology and changing user needs, and maintains its high level
of utility for the cancer research community. We will accomplish this through our three specific aims.
Aim 1. Evolve IGV to keep pace with the needs of the cancer genomics community. We will continue to
evolve IGV to leverage recent and future advances in genomics technologies and methods that are key to moving
cancer research and treatment forward. We will add new visualizations and features to better enable
interpretation and validation of complex variants from both short and long read data. Through collaborations with
other projects we will add new capabilities to better assess and interpret single nucleotide and structural variants.
Responding to IGV’s increased use for review of variants in patient tumors, we will enhance support for this task.
Aim 2. Maintain IGV to ensure continued high levels of utility, usability, and reliability. We will continue to
provide frequent software releases to address feature requests, bug reports, and other suggestions from IGV’s
community of both users and developers. Based on community input, we will review the IGV user interface to
improve usability. We will address the challenges and opportunities presented by the evolving computing and
software technology environment. We will continue to maintain the code base and downloadable installers and
update them for new releases of Java, JavaScript, external libraries, browsers, and operating systems.
Aim 3. Support the IGV user and open-source developer communities. We will continue to provide a high
level of support including rapid responses to help requests; in-depth documentation on software use; short videos
to walk users through tasks with high utility; training materials and exercises. For our vibrant, open-source
developer community that contributes to the IGV code base and uses IGV in their own applications or resources,
support includes: documentation and code examples for integrating and extending IGV; guidance on new
development through our GitHub forums; prompt review of contributions; and acknowledgement of their work.
We have extensive software engineering experience, developing and distributing IGV and other software tools
used by hundreds of thousands of biomedical researchers and clinicians worldwide. IGV’s success, user-driven
development approach, collaborative tradition, and flexible architecture make us well poised to accomplish our
aims to further transform data visualization and accelerate the pace of biomedical discovery.

Public health relevance
Project Narrative Given the enormous amount of data generated by research studies and in the clinic today, visualization is often a key element in gaining insight into the genomic basis and mechanisms of disease. These insights will help to develop hypotheses for further study, guide treatment, and point the way to new therapeutic targets. We propose to ensure that the Integrative Genomics Viewer (IGV) continues to track and respond to advances in genomics technology and changing user needs, and maintains its high level of utility for the cancer research community.